MacCHESS Synchrotron Source for Structural Biology

Project summary:
The MacCHESS Synchrotron Source for Structural Biology facilitates the utilization of both
established and emerging technologies to enable the structural characterization of proteins involved in
critically important biological processes with significant consequences for diseases such as cancer, bacterial
and viral infections, and neurodegenerative disorders. Recent upgrades to CHESS, including improvements
to the storage ring and newly designed beamlines have provided state-of-the-art facilities and enabled
greater capabilities since June 2019. MacCHESS will continue to support more than 100 investigator
projects, funded by NIH and other government institutions, through two major Technology Operations Cores.
These are: 1) Facility for Flexible Crystallography, which will take advantage of unique MacCHESS
capabilities to enable the development of new X-ray techniques that may be used to broaden our knowledge
of essential biological processes. Examples include continued development of methods for room
temperature crystallography toward identifying new structural or ligand/drug binding states, the application
of high pressure to crystals, and analysis of macromolecular motions through the study of X-ray diffuse
scattering. A high level of support for more routine macromolecular crystallography will also be provided.
These methods will help to provide important new insights including the binding interactions and
conformational transitions that cell signaling proteins and drug targets undergo which are necessary for their
function, and the macromolecular motions essential for the catalytic activities of enzymes that regulate key
metabolic processes, DNA transcription and repair, and different aspects of RNA biology. 2) Facility for
Biological Small Angle X-ray Scattering (BioSAXS), which will implement state-of-the-art hardware,
software, and expertise to support the BioSAXS technique that continues to be in high demand. In addition
to determining the shapes of proteins, nucleic acids, and larger protein assemblies in solution, BioSAXS
allows researchers to obtain information regarding global conformational changes within macromolecular
complexes (e.g., membrane receptors, RNA-splicing complexes, large or multi-subunit enzymes) and the
changes in their oligomeric states that have important functional consequences. This core will also provide
the necessary equipment and expertise for investigators interested in performing time resolved BioSAXS or
BioSAXS studies conducted under high pressure. MacCHESS will provide a strong Administration Core to
support these activities and will continue to educate and help to train users and investigators from the
biomedical research community new to the field of structural biology, through a Training and Outreach Core.
Collectively, these efforts will offer unique opportunities to our users for pursuing some of the most
challenging questions in structural biology and for obtaining structure-function information that will ultimately
highlight novel therapeutic targets and aid in the development of clinical strategies for dealing with disease.

Public health relevance
Project narrative: High-resolution structural information is essential for understanding the molecular basis of a number of diseases. Among the important requirements for obtaining such information are (1) the routinely available capability to study the conformation and oligomeric states of biomedically relevant proteins and protein complexes both in crystals and in solution, including methods for handling the poorly-diffracting crystals often generated by membrane-receptors, ion channels, and signaling proteins, and (2) the means to continue to improve on the available techniques, extending our knowledge of complex systems which are currently poorly understood. MacCHESS will provide the necessary facilities and access to technology to help to generate structure- function information of great interest to the biological and biomedical communities.